Solid phase transition as a facilitator of olfactory receptor choice

Project Summary
Singular and stable olfactory receptor (OR) gene choice is paramount for odor detection and identification by
mammalian olfactory systems. We previously showed that a complex network of interchromosomal interactions
between intergenic OR enhancers, the Greek Islands, reduces the complexity of choice to a handful OR alleles
that transiently contact ~6 Greek Island hubs assembled in each olfactory neuron. Subsequently, an RNA
mediated symmetry breaking process silences all but one of the co-transcribed ORs, assuring stable association
of that allele with the Greek Island hub for the life of the neuron, while the other ORs became permanently
silenced. Here, we show that the unusual stability and specificity of ultra-long-range Greek Island interactions
are explained by solid phase transitions of Lhx2 and Ldb1 proteins in the Greek Island hub. Our in vitro data
show that these two proteins promote assembly of gel-like nucleoprotein complexes when incubated with Greek
Island DNA, which form in a DNA-sequence-dependent fashion. Preliminary in vivo imaging data suggest that
these DNA-induced solid phase transitions may also take place in vivo, in cultured primary olfactory neurons,
providing an exciting and novel mechanism that explains both the specificity and stability of ultra-long-range cis
and trans genomic interactions. We therefore propose experiments that will confirm the concept of DNA-induced
solid phase separation as a means of 3D genome organization, experiments that will explore the exact role of
these biophysical transitions in the stability and specificity of genomic interactions, and experiments that will test
whether solid phase transitions in the Greek Island hub protect the chosen OR allele from silencing by the liquid
phases of the surrounding heterochromatin. Beyond providing significant mechanistic insight to the genomic
choreography that culminates in singular and stable OR gene choice, our studies will provide generalizable
principles for the mechanisms of long-range genomic interactions, and paths for future therapeutic interventions,
as there is emerging evidence for the role of such genomic interactions in human disease.

Public health relevance
Project Narrative Long-range genomic interactions play a critical role in cardiomyocyte development and function, in the effects of repeat expansion in fragile X-syndrome, in COVID-19-induced anosmia, and in the development of irritable bowel syndrome. Moreover, malaria parasites deploy long-range genomic interactions to evade immune responses in antigenic variation. Thus, deciphering the molecular mechanisms of ultra-long-range genomic interactions will pave the way for therapeutics that target or stabilize genomic interactions associated with human disease.